Building 41 Flow Cytometry Core

This project provides flow cytometry expertise and support for biological research projects in the Center for Cancer Research (CCR), National Cancer Institute (NCI). Since January 2025, this project has provided instrument training for 23 postdoctoral and postbaccalaureate fellows from Pediatric Oncology Branch, Lab of Receptor Biology and Gene Expression, Lab of Cancer Biology and Genetics, and Thoracic and GI Malignancies Branch. In addition, this project has continued to develop and validate two 42-color spectral flow cytometry panels using the Sony and Cytek spectral flow cytometry platforms for future use in HIV Vaccine Clinical trials. Expertise for immunophenotyping (human, murine, non-human primate), cell cycle (PI, DAPI, DyeCycle Violet), apoptosis (Annexin V, Active Caspase 3, TUNEL, JC1), fluorescent protein analysis and cell sorting (GFP, mCherry, CFP, JFX650, JF549, JFX554, TMR), mitochondrial metabolism (MitoTracker, JC1, SCEINTH), cell proliferation (EdU, BrdU, CFSE, Ki67), infectious cell sorting (HIV) and other functional flow cytometry assays (intracellular cytokine, activation markers) have been provided in the past year to researchers in multiple labs and branches at CCR.